Lifespan effects of prenatal and perinatal opioid exposure on the brain's metabolic-epigenetic axis

PROJECT SUMMARY
The rising opioid use rates have led to a significant increase in children exposed to opioids in utero, with adverse
effects on both the placenta and developing brain. These effects include alterations in brain structures, including
the cortex, hippocampus, and cerebellum. Affected children also have an increased susceptibility to
neurodevelopmental disorders such as neonatal opioid withdrawal syndrome, as well as deficits in speech,
cognition, and executive function. Despite these known effects, there are no neuroprotective treatments due to
limited knowledge of the underlying molecular mechanisms.
Here, we propose an innovative strategy to unravel the lifelong impact of prenatal opioid exposure on brain
development. We will employ a well-characterized model of early-life morphine exposure to identify how opioid
exposure during brain development disrupts the metabolic-epigenetic axis, potentially disrupting long-term cell
type-specific maturation. In this model, previous bulk RNA sequencing has identified mitochondrial dysfunction,
especially in the prenatal period. In other models of prenatal opioid exposure, mitochondrial dysfunction persists
into adulthood and opioid exposure increases susceptibility to other brain injuries, like traumatic brain injury.
Epigenetic patterns are frequently disrupted by metabolic anomalies. Therefore, we will explore the effects of
opioid exposure on mitochondrial function and epigenetic regulation throughout the lifespan.
In both the fetal and juvenile First, we will employ advanced in utero metabolic imaging with 4D-Oxywavelet MRI
and molecular profiling to correlate mitochondrial dysfunction with single-nucleus joint transcriptomics and
epigenomics in the placenta and different regions of the fetal brain (cortex, hippocampus, and cerebellum) after
opioid exposure throughout gestation. Then, in exposure juvenile animals, we will perform brain region-specific
mitochondrial function profiling in the cortex, hippocampus, and cerebellum. We will subsequently perform single-
nucleus transcriptomic and epigenetic profiling in the same animals and brain regions. Both approaches will
allow us to directly correlate the variability of metabolic disruption with cell type-specific molecular profiles,
allowing us to dissect the interplay between metabolism and the epigenome in developmental opioid exposure
at a resolution that has never occurred before. We hypothesize this approach will also provide insight into the
potential biological underpinnings for the variability of neurodevelopmental outcomes seen from opioid exposure.
By performing this comprehensive assessment of how the metabolic-epigenetic axis is disrupted by
developmental opioid exposure, we will be able to identify novel, lifespan neuroprotective agents. Additionally,
the approach is flexible and could be applied to study other prenatal exposures, including exposure to other
substances, that disrupt the metabolic-epigenetic axis.

Public health relevance
PROJECT NARRATIVE Prenatal opioid exposure leads to significant alterations in brain structures like the cortex, hippocampus, and cerebellum, resulting in heightened susceptibility to neurodevelopmental disorders, but there are no neuroprotective treatments due to a lack of understanding of the molecular mechanisms involved. This study aims to investigate how opioid exposure disrupts the metabolic-epigenetic axis throughout brain development, using advanced imaging, mitochondrial profiling, and single-nucleus molecular profiling to analyze mitochondrial dysfunction and epigenetic changes in the placenta and brain. By identifying how these disruptions impact cell maturation throughout the lifespan, this research could uncover new neuroprotective therapies and inform future studies on other prenatal exposures.